Assay development and optimization for a high throughput screen to detect compounds increasing secretion of C150S mutant Uromodulin

PROJECT SUMMARY/ABSTRACT
Heterozygous mutations in Uromodulin (UMOD) cause autosomal-dominant tubulo-interstitial kidney disease
(ADTKD-UMOD) which results in chronic and end-stage renal disease, and so far no specific treatment is
available for these patients. In different murine and cell culture models, it has been found that UMOD mutations
impair UMOD protein trafficking. Misfolded UMOD accumulates within the endoplasmic reticulum, resulting in
apoptosis of the thick ascending limb (TAL) cells and renal fibrosis. We have established a cell culture-based
assay which monitors secretion dynamics of wild-type (WT) and human mutation C150S UMOD in culture
medium of stable cell lines expressing luciferase-tagged UMOD plasmids, thereby measuring a disease-relevant
endpoint. Our objective for this proposal is to identify and chemically optimize compounds that enhance the
secretion of retained mutant UMOD protein as a new therapeutic modality for treating ADTKD-UMOD. Our
hypothesis is that increasing secretion of retained, mutant UMOD protein will reduce cellular apoptosis, and will
mitigate chronic kidney disease in ADTKD-UMOD. In preliminary data, we screened 8,000 compounds of a
subset chemical library for enhancing the secretion of C150S UMOD. We identified five hits that increased C150S
UMOD secretion to at least 75% compared to WT UMOD, providing proof-of-concept for our approach. The
rationale of this project is to identify potent compounds accelerating secretion of different UMOD mutations using
a human kidney cell line to ameliorate ADTKD-UMOD. After screening our established canine C150S UMOD
expressing stable cell line against the optimized over 150,000 compounds containing UTSW chemical library,
we will counter-screen identified candidates against stably transfected human kidney cell lines expressing the
C150S and five other human UMOD mutations. All of these mutations affect one of 24 disulfide bridges, which
are involved in up to 60% of UMOD mutations. With this approach, we attempt to treat a maximum number of
patients. In aim 1, we will first optimize all plate-based secondary assays including a UMOD ELISA, an assay
testing for non-specific upregulation of the secretory pathway, a caspase 3/7 assay, and an assay for testing
different UMOD mutations. In aim 2, we will conduct a large phenotypic HTS of the over 150,000 compounds
containing UTSW chemical library and will confirm hits in triplicates. A subsequent cell toxicity assay will exclude
compounds resulting in false positive hits due to UMOD release caused by significant toxicity. Secondary assays
optimized in aim 1 will be performed to decrease the number of promising hits. In aim 3, the best candidates will
be tested in a primary cell culture model of the TAL from WT and a mutant Umod mouse model. We will test the
stimulatory effect of compounds on mutant UMOD secretion by studying current density of the calcium channel
TRPV5. SAR and chemical optimization of the best hits will be studied and tested in the assays outlined in aims
1 and 3. Finally, baseline pharmacology characteristics will be evaluated. Results from these experiments will
be significant as they may provide novel and innovative therapeutic options for ADTKD-UMOD patients.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to NIH’s mission since we want to identify a new therapeutic option for patients with autosomal dominant tubulo-interstitial kidney disease caused by Uromodulin mutations (ADTKD-UMOD). This condition is caused by heterozygous mutations in Uromodulin, which result in a misfolded protein, Uromodulin accumulation in the endoplasmic reticulum, apoptosis, renal fibrosis, and subsequently renal failure. We have been developing a cell cultured-based high throughput assay to identify compounds, which enhance mutant Uromodulin protein secretion in ADTKD-UMOD patients and thereby improve outcome of chronic and end-stage kidney disease in ADTKD-UMOD.